Assessment of Treatment with Visible Light Activated Synthetic Hypericin ointment in Mycosis Fungoides Patients.

7. Project Summary/Abstract
Mycosis Fungoides/Cutaneous T Cell Lymphoma (MF/CTCL) is a rare, indolent Non-Hodgkin's
Lymphoma (NHL), without a known cure, that presents as skin patches, plaques, tumors, or
erythroderma with significant morbidity and impact on health-related quality of life (HR-QoL).
Effective early treatment improves HR-QoL and may prevent disease progression. As per current
NCCN guidelines, many skin-directed therapies (SDTs) are used for the treatment of early stage
MF/CTCL including topicals, ultraviolet (UV) phototherapy, and radiation therapy. None have
been FDA-approved for first-line therapy and most are used off-label. Given the chronic, recurrent
nature of MF/CTCL, most patients require repeat courses of therapy and trying other therapies.
The use of several SDTs are limited by skin irritation/dermatitis and long-term cumulative toxicity.
Given this, there is an urgent need for additional SDTs for CTCL with fewer side effects. Topical
hypericin is non-mutagenic, not systemically absorbed, activated by noncarcinogenic visible light,
selectively taken up by tumor cells in the skin (up to 10-fold) and induces mitochondrial apoptosis.
Phase 1, 2 and 3 clinical studies in MF/CTCL have demonstrated safety and efficacy. A recent
multicenter, randomized, placebo-controlled, blinded Phase 3 study, enrolled 169 patients with
Stage IA, IB or IIA CTCL and administered treatments twice weekly for at least 6 weeks (Cycle
1). In Cycle 1, 116 subjects received SGX301 to 3 index lesions with an overall response rate
(ORR) of 16% compared to placebo ORR 4% (n=50, p=0.04). In Cycle 2 the ORR in patients
receiving SGX301 for both cycles (12 weeks) was 40% (p<0.0001 vs placebo or 6 weeks of
treatment). SGX301 treatment is safe and well tolerated, with potential favorable long-term safety
given its mode of action. Although the trial showed efficacy, the dosing regimen was inflexible and
short duration vs other skin-directed therapies where peak ORR can take 4-24 months of
treatment. The current proposal will study SGX301 efficacy/safety utilizing a continuous treatment
schedule for up to 1 year in an open label, multicenter clinical trial of 50 patients over 6 sites. The
Specific Aims are: 1: Define optimal duration of SGX301 therapy to maximal ORR in early stage
MF/CTCL patients on a “real world” treatment schedule up to 12 months. 2: Define safety profile
during treatment. 3: Assess efficacy of SGX301 in disease subtypes and different skin lesions
(patch vs plaque). 4: Assess genomic changes in skin/peripheral blood (utilizing high throughput
sequencing [HTS-PCR] and targeted next generation sequencing [NGS]) and apoptosis markers
(utilizing immunohistochemistry) as correlates of clinical response to SGX301 therapy.

Public health relevance
8. Project Narrative In the United States, there are approximately 2,500-3,000 new cases per year and approximately 28,000 people living with cutaneous T-cell lymphoma (CTCL), a relatively rare form of Non-Hodgkin's Lymphoma (NHL), and there is currently no FDA approved cure or first line treatment for CTCL. SGX301 (0.25% hypericin), a novel, first-in-class photodynamic therapy utilizing safe visible light for activation has received Orphan Product and Fast Track designation from the FDA and has recently shown efficacy in the study's primary and key secondary endpoints of a Phase 3 pivotal study. The primary objective of this proposal is to advance the clinical evaluation of SGX301 by conducting the clinical study RW-HPN-MF-01, “Assessment of Treatment with Visible Light Activated Synthetic Hypericin Ointment in Mycosis Fungoides (MF) Patients”, evaluating extended administration of SGX301 as a photodynamic therapy (PDT) for MF/CTCL.